Elucidating the role of cyclin G-associated kinase as a regulator of podocyte autophagy

Project Summary:
An estimated 37 million people in the US and over 800 million people worldwide are affected by chronic kidney
disease (CKD), which is defined as persistent abnormalities in the structure and/or function of the kidneys.
Integral to the filtering function of the kidney are podocytes, which are highly specialized, post-mitotic epithelial
cells that line the glomerular filtration barrier. Although damage to podocytes has been implicated in the
pathophysiology of CKD, significant gaps in our understanding of podocyte repair and maintenance hinder the
development of novel therapies that specifically mediate podocyte injury. To address this problem, I will use a
genetically engineered mouse model with a podocyte-specific knockout of cyclin G-associated kinase (GAK) to
study cellular mechanisms involved in podocyte maintenance. Our group has previously demonstrated that
podocyte-specific loss of Gak results in podocyte damage and kidney failure. Interestingly, we found that re-
expression of the truncated 62-kDa C-terminal end of GAK (C62) in mice completely rescues this severe
phenotype. I hypothesize that the 62-kDa C-terminus of GAK regulates podocyte autophagy and is indispensable
for proper turnover of cellular debris and maintenance of homeostasis. In Aim 1, I will test my hypothesis by
measuring autophagic flux in primary podocytes derived from wildtype, Gak knockout, and GAK C62 rescue
mice via western blot and immunofluorescence. Furthermore, I will assess the ability of GAK C62 to bind and
activate key autophagy regulators via western blot. In Aim 2, I will perform translating ribosome affinity purification
sequencing (TRAP-seq) on wildtype, Gak knockout, and C62 podocytes in vivo. This data-driven approach will
provide an unbiased view of pathways that are regulated by the C-terminal end of GAK in podocytes. I will
validate the results of the TRAP-seq experiment using western blot and qRT-PCR, as well as in vitro knockdown
assays in primary podocytes, targeting pathways that exhibit the highest upregulation and downregulation
between the three groups. Given that GAK is implicated in other cellular processes, this approach would enable
us to both solidify its role in autophagy and determine additional pathways specifically mediated by GAK C62.
This proposal to investigate the role of GAK in regulating autophagy in podocytes will advance our collective
understanding of mechanisms that contribute to podocyte repair and maintenance and potentially uncover
promising therapeutic targets for treating podocytopathies. Furthermore, this project is an integral component of
a comprehensive training plan that will provide me with plenty of new learning opportunities and necessary
mentorship towards my long-term goal of becoming a physician-scientist in nephrology.

Public health relevance
Project Narrative Podocytes are highly specialized cells that are essential to the proper functioning of the kidneys. While podocyte damage and loss have been implicated in the development of chronic kidney disease (CKD), gaps in our understanding of podocyte maintenance and repair mechanisms hinder the development of novel therapies that specifically mediate podocyte injury. By uncovering genes and pathways that are essential to podocyte homeostasis, this study has the potential to uncover novel therapeutic targets for CKD.